Role of IgE in human disease and immunity to ticks

Acquired tick resistance is an observation that an immune response against ticks, elicited following repetitive tick
bites, can result in interruption of tick feeding, resistance to subsequent tick bites, and ultimately reduction in the
transmission of tickborne pathogens. Evidence has been accumulating which suggests that like helminth infections
this immune response is orchestrated by the IgE antibody and allergic inflammation, spearheaded by basophils.
We have established a method to grow, identify and immortalize ultra-rare IgE encoding B cells from the
peripheral blood of allergic and parasitized individuals. We have begun identifying and recruiting research
subjects who have experienced frequent repeated tick bites, expanding our panel of human anti-tick mAbs, to
characterize the role that IgE plays in our immune defense against ticks. Nothing is known about the
immunodominant salivary allergens involved in inducing this B cell response in humans. Critical first steps in this
science, therefore, are to identify these allergens, define their location within the tick salivary gland, their life
stage abundance, the time during tick feeding they are induced, and the extent of antibody cross-reactivity
observed between tick species. B cell cultures are actively being screened using salivary gland extracts generated
from the tedious dissection of partially fed adult stage A. americanum ticks. This reagent is ideal, as it best
represents the profile of natural antigens the human is exposed to at the bite site, however, it is greatly limiting.
Fortunately, investigators have recently published the A. americanum sialotranscriptome, performing RNA
sequencing of salivary glands at multiple timepoints during tick feeding. As an extension and an offshoot of our
funded R01 (R01AI182247), we propose to use this valuable information in a supplement project. In Aim 1 we
will use the A. americanum sialotranscriptome to identify and express those allergens which are most likely to be
inducing an IgE-mediated immune response. We will focus on the early sialotranscriptome and cement, as these
are what our repeated tick bite subjects are most exposed. Common allergen homologs, exemplified by the family
of lipocalins (histamine binding tick proteins), will be examined and the most representative proteins will be
expressed. These allergens then will be used for primary B cell culture screening and to evaluate our existing
panel of mAbs. This will undoubtably result in a parallel pathway for rapid development of tick allergen-specific
human mAbs to be used in the studies proposed in our parent grant. In Aim 2 we will use our panel of human IgE
mAbs to better understand the location, distribution, and cross-reactivity profiles of tick salivary allergens. We
will use our large panel of human mAbs to assess, using immunohistochemistry and confocal microscopy, the
allergen protein location (class of acinar cells) within salivary glands of different life stages and species of tick.
This information will not only allow for a better understanding of the immunodominant salivary allergens but will
also inform our future production of salivary gland extract essential for continued development of tick-specific
human mAbs used in the studies proposed in our parent grant.

Public health relevance
The IgE antibody provides the targeting specificity for the immune cells it arms, mast cells, basophils, and eosinophils, plays a causal role in allergy, and remains understudied for its fundamental function in defending us against parasites. We set out to study the dual role of IgE in human disease and immunity to ticks. A greater understanding of the tick salivary antigens inducing IgE antibodies responsible for alpha-gal syndrome and those yielding acquired tick resistance will enable creation of new tools with potential diagnostic and therapeutic clinical uses.